TOBACCO CONTROL PROGRAM

UCSF has nationally recognized tobacco control researchers whose work has contributed substantially to what is known about nicotine addiction, the effectiveness of legislative and other policies designed to reduce tobacco use, culturally appropriate tobacco control interventions for various subgroups of the population, estimates of the costs to society of tobacco use, and other areas. The Tobacco Control Program brings 18 researchers from nine departments in four schools at UCSF. The Program stimulates plans for collaboration and for the development of shared resources that benefit multiple program members. The goals of the program are: to conduct clinical and laboratory investigations of mechanisms of nicotine addiction that can translate into more effective tobacco cessation methods;to further understand the effects of tobacco use and of exposure to environmental tobacco smoke on risk of various cancers, including studies of genetic markers of susceptibility (gene-tobacco interactions) and investigation of racial/ethnic differences in measures of tobacco exposure and tobacco-related disease risks;to determine effective approaches for tobacco prevention and cessation in defined populations, through controlled trials and through monitoring and surveillance of community-based tobacco control programs;to provide estimates of the economic costs of tobacco use to society;to conduct research on legislative and other tobacco-related policies, including examining the formation and implementation of such policies, analyzing the effectiveness of such policies in reducing use of tobacco and exposure to environmental tobacco smoke, and assessing the quality and dissemination of tobacco-related research;and to document the extent of external medial influences on tobacco use in our society. The Program has $8,250,251 Total peer reviewed support for the last budget year. The Program has 19% intra-programmatic and 11% inter-programmatic publications.